Development of an Interactive Bioethics Training Module for Healthcare Providers Treating Patients Who Need Liver Transplant for Alcohol-associated Liver Disease

PROJECT SUMMARY
Alcohol-associated liver disease (ALD) accounts for nearly half of liver-related deaths in the United States and
is the leading indication for liver transplant (LT). Historically, many transplant centers have required a 6-month
alcohol abstinence period to qualify for a liver transplant. However, the subset of patients with ALD who have
severe alcoholic hepatitis (SAH) are unlikely to survive 6 months, with 70-80% mortality in 3 months. A 6-
month abstinence requirement limits access to LT for patients with SAH. Early liver transplantation (ELT), or
the practice of proceeding with a transplant without waiting for a 6-month abstinence period, is the only life-
saving treatment available for most patients with SAH. Since its introduction a decade ago, ELT for SAH has
sparked debate on issues of fair and responsible allocation of scarce donor organs. Healthcare providers who
treat patients with ALD have expressed conflicting feelings and moral distress about center-level ELT
practices, particularly related to the selection process and post-transplant clinical care. Recent research data
providing evidence of successful patient outcomes after ELT have not resolved healthcare providers’ moral
distress, especially related to stigmatization of patients with alcohol use disorder and concerns about
trustworthiness or deservingness. Healthcare providers’ perceptual schemas and unconscious biases are
persistent barriers to the expansion and sustainment of ELT.
To aid in the expansion of ELT nationally, ethics training for healthcare providers and research collaborators is
needed. Bioethics educational interventions have been shown to alleviate moral distress, increase resilience,
and empower healthcare workers to exercise moral agency. We will develop a novel, interactive training
module that situates key bioethics concepts within real clinical practice and teaches foundations of ethical
reasoning to help healthcare providers navigate moral distress related to ELT. We will use design-based
research methodology to create an online training module that will include a) foundations of bioethics and
ethical reasoning and their application to clinical scenarios in ELT b) self-reflexive exercises to examine
unconscious biases and c) selectable instructional pathways tailored to the learner’s moral distress. The
training module will be part of a larger endeavor to share resources, including an ethical framework (as
outlined in the parent award) and educational materials, for transplant centers nationally. We envision this
module to be the first in a series, culminating in a comprehensive and customizable online bioethics
curriculum.

Public health relevance
PROJECT NARRATIVE Early liver transplantation (ELT), or the practice of proceeding with a transplant without waiting for a conventional 6-month alcohol abstinence period, can be an effective, life-saving treatment for patients with severe alcoholic hepatitis (SAH), but is associated with controversy and healthcare provider moral distress. Bioethics education has been shown to illuminate unconscious biases and alleviate moral distress in other fraught clinical contexts. We will develop a novel, interactive bioethics training module using examples from real clinical practice to help healthcare providers navigate moral distress and reduce barriers to expansion and sustainment of ELT.